Residual Kidney Function in ESRD: Measurements, Serum Markers and Outcomes

DESCRIPTION (provided by applicant): Over a 100,000 persons in the US started dialysis and more than 350,000 people were on maintenance dialysis in 2006; a number expected to grow to over half a million by the year 2020. The high first-year mortality for incident dialysis patients has not decreased in the last 11 years and 60% of the dialysis patients die within five years of starting dialysis. Therapies to improve dialysis care are sorely needed but most recent clinical trials to reduce dialysis mortality have been negative. Kidney function after starting dialysis, referred to as residual kidney function (RKF), is a strong predictor of survival in dialysis patients. RKF, even at the low levels present in dialysis patients is important for clearing uremic toxins and preventing volume overload and its sequelae such as hypertension and heart failure. Preserving RKF, as an integral part of an overall dialysis care plan, offers the hope of improving dialysis care and improving the dismal dialysis survival. RKF, however, is difficult to assess. There are no methods for assessing RKF similar to the estimation of GFR by serum creatinine in non-dialysis patients. Timed urine collection, performed over 24-48 hours is the only method available at this time to assess RKF in dialysis patients. The overall goals of this proposal are: (1) to develop simple methods for direct measurement of GFR in dialysis patients using a very small dose of iohexol, a radiologic contrast agent referred to as the new standard for measuring GFR, (2) test if two endogenous low molecular weight proteins (beta-trace protein [BTP] and cystatin C), that are excellent serum markers of GFR but not removed by dialysis, can be used to estimate GFR in dialysis patients similar to the estimation of GFR from serum creatinine in non-dialysis patients, (3) determine the risk of mortality and morbidity associated with low RKF, and (4) design and conduct a pilot randomized clinical trial to determine if RKF can be preserved by treatment with angiotensin converting enzyme inhibitors. The candidate for this mentored Career Development Award is an Instructor of Medicine in the Division of Nephrology at Johns Hopkins University and his career goal is to become an independent clinician-investigator in the area of end-stage renal disease (ESRD). This award will allow him to undergo a rigorous program of didactic education in epidemiology and biostatistics complemented with a practical experience in conducting clinical research. These structured career development activities, occurring under the close guidance and supervision of leaders in the field of kidney disease epidemiology, the supportive environment of Johns Hopkins University as well as the Welch Center for Prevention, Epidemiology, and Clinical Research will allow him to answer important scientific questions and develop into an independent clinical investigator.

Public health relevance
PUBLIC HEALTH RELEVANCE: Survival on dialysis is poor with only 4 out of 10 people surviving beyond 5 years. Kidney function, even after start of dialysis, plays an important role in clearing kidney failure toxins and improves survival. This research project will develop methods for measuring kidney function in dialysis patients and test if treatment with angiotensin converting enzyme inhibitors can preserve kidney function in dialysis patients. Survival on dialysis is poor with only 4 out of 10 people surviving beyond 5 years. Kidney function, even after start of dialysis, plays an important role in clearing kidney failure toxins and improves survival. This research project will develop methods for measuring kidney function in dialysis patients and test if treatment with angiotensin converting enzyme inhibitors can preserve kidney function in dialysis patients. __SpecificAimsTextDelimiter__ Residual Kidney Function in ESRD: Measurements, Serum Markers and Outcomes A. SPECIFIC AIMS Optimizing care for dialysis patients remains a major challenge as the overall death rate remains dismally high and clinical trials of dialysis dose have been largely negative.1, 16-18 Kidney function in dialysis patients, also referred to as the residual kidney function (RKF), is strongly associated with improved survival; each 1 ml/min/1.73m2 higher glomerular filtration rate (GFR) is associated with an 11 - 48% lower risk of death.19-26 RKF, even at the low GFR levels in ESRD patients, plays a crucial role in the clearance of uremic toxins that are not cleared by dialysis and prevents volume overload and its sequelae such as left ventricular hypertrophy and congestive heart failure (CHF). The 2006 National Kidney Foundation's Kidney Disease Outcome Quality Initiative (K/DOQI) Guidelines recommend "striving to preserve RKF in hemodialysis patients (grade A recommendation)".7 GFR is widely accepted as the best overall measure of kidney function 27 but is difficult to assess in dialysis patients. The only current method to estimate GFR in dialysis patients is by a 24-48 hour urine collection. Urine collection, however, is cumbersome and <5% of all US incident hemodialysis patients undergo annual urine collections.28 In dialysis patients, no methods currently exist for estimating GFR similar to GFR estimation from serum creatinine in non-dialysis patients. Development of simple and reliable methods for assessing RKF would be of great value in guiding future research in preserving RKF and improving dialysis care. Plasma iohexol clearance, considered by some as the new standard for GFR measurement, can allow direct measurement of GFR in dialysis patients.29, 30 Data also suggest that serum levels of low molecular weight proteins, such as beta-trace protein (BTP) and cystatin C, that are freely filtered by the glomerulus but not removed by dialysis, may allow estimation of GFR in dialysis patients.13, 15, 31, 32 Specific Aim 1: To prospectively develop methods for measurement and estimation of GFR in ESRD patients (RKF) on hemodialysis (HD) and peritoneal dialysis (PD). In a pilot study (n = 50), we will measure GFR using plasma and urinary iohexol clearance and develop a simple GFR measurement protocol requiring blood samples at two time points. 150 additional participants will undergo GFR measurement using the new protocol. 50 PD patients will be included in the 200 participants in both studies. Serum GFR markers (BTP and cystatin C), will be measured in all participants. Hypothesis 1a (pilot study; n=50): Two time point plasma iohexol clearance will provide an accurate and precise measure of GFR (measured by urinary iohexol clearance). Hypothesis 1b (full study; n=200): Serum GFR markers (BTP and cystatin C) will provide an accurate and precise estimate of GFR (measured by plasma iohexol clearance). Specific Aim 2: To study the association between RKF and morbidity and mortality in incident dialysis patients participating in the NIH-funded CHOICE Study (n=823; recruited in 1995-1998) and the PACE Study (n=1000; recruiting 2008-2011). Serum GFR markers (BTP and cystatin C) will be measured at baseline and year 1 in both studies. 150 participants of the PACE Study will also be enrolled in an ancillary study of GFR measurement (Aim 1). 2. 1. Cross-sectional associations between RKF and outcomes unique to each study Hypothesis 2a (CHOICE Study): Lower urine output will be associated with higher levels of serum GFR markers as well as higher uremic toxins (e.g. urea, p-cresol sulfate, indoxyl sulfate, kynurenic acid). Hypothesis 2b (PACE Study): Lower GFR (directly measured in 150 and estimated in 1,000) among dialysis patients will be independently associated with consequences of lower GFR such as greater left ventricular mass index and lower left ventricular ejection fraction. 2. 2. Longitudinal associations between RKF and outcomes Hypothesis 2c (CHOICE and PACE Studies): Higher levels of serum GFR markers will be independent risk factors for mortality (all-cause and cardiovascular) and hospitalizations (all-cause and CHF). Specific Aim 3: To conduct a pilot randomized, double-masked, placebo-controlled trial evaluating the use of angiotensin-converting enzyme (ACE) inhibitors to preserve RKF in HD patients. 50 incident HD patients will be randomized to treatment with quinapril or placebo. GFR will be measured using iohexol clearance at 0, 6 and 12 months. Serum GFR markers (BTP and cystatin C) will be measured quarterly. Hypothesis 3a: Estimates of compliance with study protocol and RKF progression rates will support the conduct of a multicenter, randomized clinical trial. The overall goals of this proposal are: (1) to develop a simple, two time-point plasma iohexol clearance protocol for measurement of GFR in dialysis patients, (2) to replace the use of 24-48 hour urine collections with estimation of GFR using serum BTP and cystatin C, (3) to quantify the risk associated with low RKF, and (4) to establish a solid foundation for a pilot trial of preserving RKF using ACE inhibitors Outcome research on RKF was ranked as a "Critical Research Recommendation" by the 2006 K/DOQI working group.7 These mentored clinical research projects pursue independent research ideas of Dr. Shafi while utilizing the expertise of his well-established and recognized mentors and collaborators as well as the substantial infrastructure at the Johns Hopkins Medical Institutions and The Welch Center for Prevention, Epidemiology and Clinical Research. This series of research projects will allow Dr. Shafi, under close guidance of his mentors and collaborators, to acquire the necessary knowledge and experience to develop into an independent clinical investigator.